Legislative Agriculture Chairs Summit

Project Summary/Abstract
State Agriculture and Rural Leaders application to Food and Drug Administration_Research CFDMA
93.103, FDA Scientific Conference Grant Program
With this application, State Agriculture and Rural Leaders (SARL) requests funds from the Food and Drug
Administration Office of Regulatory Affairs to partially support the Legislative Agriculture Chairs Summit, the
only meeting of its kind in North America. The Summit brings together the leading state legislators and other
related state officials that are passionate about issues related to the production of food.
The long term goal is to develop state policy makers with broader knowledge of issues related to food,
drugs and health that will provide for better policy decisions at the state level to assure the safety, efficacy
and security of our food supply. The Summit provides high quality educational programming, opportunities
for state legislators to network with FDA officials, scientific experts and each other. History has shown that
attendees return to their home state/territory and share the knowledge gained, utilize the networking
contacts and are highly influential in policy decisions. Since the states and FDA share similar authorities,
missions and responsibilities, expanding the knowledge base and leadership abilities of state legislators
assists the FDA in the implementation of their mission.
With this Small Scientific Conference Grant, SARL will be able to cover the travel expenses for the best
speakers for the Summit. This also helps to free up Summit funds to assist state legislators with travel
expenses to attend the 2 ½ day Summit. The Summit has a history of attendance of leaders from more than
90% of the state legislative chambers well as Puerto Rico and the Virgin Islands.
The Legislative Agriculture Chairs Summit began in 2002 through the efforts of a group of state legislators
that felt that the divide between food production and members of state legislatures was increasing. They
were concerned by the growing disconnect shown by state officials on knowledge of issues important to
food production and health. The Summit is non-partisan and targets legislative leadership from all political
parties and as well as actively seeking participation from the National Legislative Black Caucus, the
National Caucus of Native American State Legislators and the National Foundation for Women Legislators.
The 2018 Summit will be held in Kansas City, Kansas, January 5-7.
Approximately 40 percent of the agenda is directly related to food, drugs or health care. Regardless of the
topic, speakers focus on science based dialogue, and are charged to actively engage the legislators on
every topic, seek solutions to the issues and provide attendees with action items.

Public health relevance
Project Narrative State Agriculture and Rural Leaders, Food and Drug Administration_Research CFDMA 93.103, FDA Scientific Conference Grant Program Application The Legislative Agricultural Chairs Summit is a two day Summit that serves key state legislators and policy makers that are dedicated to the development of good state policy related to food and agriculture. The Legislative Agricultural Chairs Summit is consistently identified in evaluations as the best meeting attendees participate in, they trust the scientific based information that often addresses issues directly within the Food and Drug Administration’s oversight, including such topics as food safety, raw milk, animal antibiotic use, state regulation of dietary supplements, terrorist actions on our food supply, bottled water and most recently opioid and related addictions in rural communities and rural health care. It is of utmost importance that state legislators are provided the non-partisan scientific knowledge gained at the Legislative Agricultural Chairs Summit so that they are better prepared to understand FDA regulations and harmonize state policy related to food and health when necessary.